Genome-wide synthetic lethal screening for vulnerabilities in a cell model of succinate dehydrogenase-loss paraganglioma

Abstract: Genome-wide synthetic lethal screening for vulnerabilities in a cell model of succinate
dehydrogenase-loss paraganglioma
This proposal focuses on the molecular pathology of familial paraganglioma (PGL). Paradoxically, this
remarkable neuroendocrine cancer is caused by inherited mutations that inactivate succinate
dehydrogenase (SDH), an enzyme of the mitochondrial tricarboxylic acid (TCA) cycle. A fundamental scientific
understanding of the molecular basis of this tumor is lacking, limiting powerful approaches that might be
identified to exploit unique vulnerabilities due to the fundamental metabolic defect in this cancer. The links
between SDH loss and tissue-specific tumorigenesis remain unknown, and conventional preclinical
models have been unavailable. The current hypothesis for PGL tumorigenesis invokes loss or inactivation of
both parental copies of any of the four SDH subunit genes (A-D). The subsequent accumulation of succinate
competitively inhibits the activities of several dioxygenase enzymes that normally suppress hypoxic signaling
and demethylate histones and DNA. Despite this general mechanistic model, other mechanisms are possible
and it is unclear what unique vulnerabilities may be present in SDH-loss cells that could permit targeted
therapies. We hypothesize that an unbiased genome-wide lentiviral CRISPR screen will identify genes
whose loss displays synthetic lethality with SDH loss. This hypothesis is supported by previous successful
work in our labs identifying genes whose loss confers resistance to multiple forms of endocrine therapy in
ERα+ and ERβ+ breast cancer cells. Important new PGL cell models have become available in the form of
Sdhblox/lox and Sdhb-/- immortalized mouse chromaffin cells (imCC). This positions us ideally to conduct and
analyze an unbiased genome-wide synthetic lethal screen using an available CRISPR single guide RNA
(sgRNA) library. Aim 1 will undertake a paired unbiased lentiviral CRISPR screen in matched normal and
SDH-loss imCC lines. Aim 2 will complete data analysis to identify candidate synthetic lethal genes. Aim 3 will
complete independent validation of representative synthetic lethal genes and pathways. Finally, Aim 4 will
implement a mouse allograft tumor model to monitor selective inhibitory effects of nominated target gene
knockdown in Sdhb-/- vs. Sdhblox/lox imCC. This project is unique in being the first unbiased synthetic
lethal screen addressing the unmet cancer needs of SDH-loss familial PGL patients. Because SDH
genes are tumor suppressors in other cancers, including gastrointestinal stromal tumor (GIST) and some
kidney cancers, identifying potential vulnerabilities in SDH-loss cells may be broadly applicable clinically.

Public health relevance
Narrative Paraganglioma and pheochromocytoma are rare cancers that can run in families and can spread and kill patients. We are studying the unusual errors in gene recipes that cause these tumors. The current project uses a method to identify additional gene recipes required only by the tumor cells as clues to possible new therapies.